Implementing a digitally-enabled community health worker intervention for patients with heart failure

Project Summary/Abstract
Heart failure (HF) 30-day readmissions generate over a third of HF healthcare costs in the US and are the leading
cause of US 30-day readmissions. Drivers of HF readmissions include increasing complexity associated with
clinical, social, and behavioral factors. Despite numerous interventions, readmission rates remain elevated and
a quarter of these could be prevented by a multidisciplinary approach promoting better connections to and
communication with clinical care teams while addressing social and behavioral barriers to HF care. Community
health workers (CHWs) are members of medical teams who address social, behavioral, and basic clinical factors
influencing health outcomes while fostering patient connections to and communication with care teams. CHW
care is one of a few interventions shown to reduce readmissions in patients with chronic disease. However, CHW
care relies on intensive 1:1 patient care models that do not leverage technology which limits efficiency and
scalability. There has been limited attention on developing technology-based interventions in CHW care to
reduce HF 30-day readmissions. A HF mobile phone application-based digital platform that utilizes artificial
intelligence driven biometric data to minimize false alarms, promotes early identification of true decline, and
encourages communication with providers was developed in 2016 to reduce HF 30-day readmissions.
Preliminary clinical trial data for the digital platform has been promising. A prototype designed for patients with
HF and the CHWs caring for them has recently been created. The current proposal will assess the acceptability,
feasibility, and preliminary effectiveness of a digitally-enabled CHW intervention to reduce HF 30-day
readmissions. Aim 1: Identify behavioral (e.g., diet, activity) and social (e.g., socioeconomic status, social
supports, living situation) factors that influence HF outcomes relevant to a digitally-enabled CHW intervention by
performing semi-structured interviews with 30 patients with HF and 20 CHWs. Aim 2: Test usability of a digitally-
enabled CHW intervention (focused on CHW workflow integration) in 10 patients with HF in an open pilot trial.
Aim 3: Assess the acceptability, feasibility, and preliminary effectiveness of implementing a digitally-enabled
CHW intervention compared to CHW care to reduce HF 30-day readmissions within a pilot RCT (n=50). The
candidate’s overall career goals are: to identify social and behavioral drivers of HF/cardiovascular clinical
outcomes; to develop expertise in qualitative methods, behavioral science, and RCTs; and ultimately, to develop
interventions that improve care and reduce costs in HF/cardiovascular disease and other NHLBI diseases seen
by generalists. This training plan includes strong mentorship, formal coursework, and scientific meetings with
cohesive training in behavioral and social sciences, qualitative research, and the conduction of RCTs. This
proposal investigates a potentially transformative intervention that addresses important gaps in the literature by
assessing the acceptability, feasibility, and preliminary effectiveness of a digitally-enabled CHW intervention in
reducing 30-day readmissions and improving patient engagement.

Public health relevance
Project Narrative: Despite ongoing efforts to improve outcomes in heart failure (HF), a leading cause of mortality and elevated healthcare costs, 30-day HF readmission rates remain elevated and a quarter of these are preventable. Community health worker (CHW) care delivery has been shown to improve healthcare outcomes but inefficiency limits its scalability. Implementation of a 30-day digitally-enabled CHW intervention for HF patients may provide support for similar interventions in larger HF/cardiovascular populations by reducing 30-day readmissions and improving patient engagement.